Craniofacial Morphogenesis in Prenatal Alcohol Exposure

ABSTRACT
Prenatal alcohol exposure (PAE) remains a leading cause of permanent neurodevelopmental disability.
Diagnosis is often initiated by a distinctive craniofacial appearance that originates, in part, from the apoptotic
deletion of craniofacial progenitors, a stem cell lineage called the Neural Crest. In the prior award period, we
demonstrated that alcohol causes nucleolar stress in neural crest through its suppression of Ribosome
Biogenesis (RBG), and this suppression is causative in their MDM2/p53-mediated apoptosis. We further
showed that this nucleolar stress originates from alcohol’s activation of AMPK, which suppresses TORC1 and
the RPS6K-mediated stimulation of RBG. How alcohol activates AMPK is unknown. Studies in this competing
renewal will identify the underlying mechanism through which AMPK initiates this nucleolar stress in neural
crest. Specifically, we test the novel hypothesis that alcohol causes nucleolar stress because it suppresses the
metabolic reprogramming (Warburg effect) that is essential to sustain their high rates of RBG and proliferation.
Aim 1 shows that neural crest rely on glycogen to fuel their Warburg effect, and that alcohol reduces their
glycolysis, in part, because it suppresses glycogenolysis. Aim 2 shows that this reduction in glycolysis
activates AMPK, which then suppresses this glycolytic reprogramming via the Hippo-mediated repression of
YAP/TAZ, which upregulates glycolytic gene expression during reprogramming. Aim 3 shows that alcohol’s
parallel suppression of Oxidative Phosphorylation (OxP), plus the neural crest’s exclusive reliance on glucose,
prevents OxP from rescuing the cells from apoptosis. Studies utilize the established mouse neural crest
primary cell line, O9-1, which recapitulates cranial neural crest fates and development. The involvement of
these signaling pathways is tested functionally using molecular approaches including small molecule inhibitors
and transfection with gain- and loss-of-function effectors. Their metabolic activity is directly quantified using
real-time cellular respirometry (Seahorse, Oroboros O2k) to dissect their fuel choice and OxP activity. RBG
consumes ~80% of total ATP generation in dividing cells, and the neural crest cell doubling time is just 19-
22hr. Our pilot data show they have an exceptional metabolic rate that is necessary to meet their high
nucleotide and ATP demands. Thus, like cancer cells, neural crest relies on the Warburg effect to support
these processes, and alcohol’s disruption of this metabolism initiates their nucleolar stress and p53-mediated
apoptosis. This mechanism explains why the cranial neural crest is so vulnerable to alcohol. Moreover,
because we reported elsewhere that nucleolar stress also drives the apoptosis of primary neural stem cells,
this may represent a broader and novel mechanism that underlies alcohol’s developmental toxicity.

Public health relevance
PROJECT NARRATIVE Fetal alcohol spectrum disorders (FASD) are a leading cause of neurodevelopmental disability. Affected individuals may display a characteristic facial dysmorphology, and studies herein investigate the metabolic- related mechanism by which alcohol causes the apoptotic deletion of neural crest progenitors, a unique neuroprogenitor stem cell population that forms these facial structures. Findings address our knowledge gap in understanding this mechanism and inform why the early embryo and fetus is so vulnerable to the damaging effects of prenatal alcohol exposure.